Genetic Association Studies in African American Colorectal Cancer Patients

DESCRIPTION (provided by applicant): Colorectal cancer (CRC) is a significant cause of cancer morbidity and mortality affecting almost 150,000 Americans yearly. African Americans have the highest CRC incidence and mortality of all US populations. These disparities have not been explained, and biological risk factors including genetic susceptibility to CRC are understudied in African Americans. I am a gastroenterologist who seeks to develop a career as an independent translational physician-scientist in CRC genetics. My long-term career goals require me to obtain additional training in: 1) molecular and statistical genetics; and 2) cancer biology. The 5-year career development program described in this application will take place at the University of Chicago which distinguishes itself in the field of human and cancer genetics especially in admixed populations. I am fortunate to have key collaborators at the University of North Carolina and the University of Illinois Chicago, and together we have DNA from over 1000 African American CRC patients and 1000 African American control subjects available for my proposed study. Dr. Nancy Cox, Professor of Medicine and Chief of Human Genetics, is my mentor and will provide expertise in statistical genetics. Dr. Nathan Ellis, Associate Professor of Medicine, is a co-mentor and will provide expertise in CRC molecular genetics. An inter-disciplinary Advisory Committee comprised of Dr. Rick Kittles, an expert in genetics of admixed populations, Dr. Olufunmilayo Olopade, an internationally recognized leader in cancer genetics, and Dr. Eugene Chang, a successful physician-scientist in gastroenterology, will guide and advise me during this development period. The broad objectives of this research proposal are the identification of genetic susceptibility factors that contribute to risk of CRC development in African Americans. I will study single nucleotide polymorphisms (SNPs) discovered using genome-wide association studies in European populations. Regions containing these SNP are likely to harbor functional variants. African Americans are an ideal population in whom to identify functional variants because their genomes exhibit less linkage disequilibrium. To this end, I propose three specific aims: 1) Validate candidate CRC-associated regions in African American cases and controls; 2) Discover novel SNPs in CRC-associated regions by targeted resequencing using next-generation sequencing technologies; and 3) Identify putative functional variants in candidate CRC-associated regions that can be further evaluated in future functional studies. By the end of my career development period, I will be uniquely equipped to undertake further translational research in CRC genetics. My long-term research goals are to understand genetic susceptibility in CRC pathogenesis and to study how genetic susceptibility factors can be used to risk stratify individuals for CRC screening and thereby prevent disease especially in high risk but understudied populations like African Americans.

Public health relevance
PUBLIC HEALTH RELEVANCE: Of all US populations, African Americans have the highest incidence and mortality of colorectal cancer. Reasons for these differences are not explained, and hereditary factors have not been extensively studied in this high risk population. The goal of our study is to better understand hereditary factors that increase risk of colorectal cancer especially in African-Americans. Project Narrative Of all US populations, African Americans have the highest incidence and mortality of colorectal cancer. Reasons for these differences are not explained, and hereditary factors have not been extensively studied in this high risk population. The goal of our study is to better understand hereditary factors that increase risk of colorectal cancer especially in African-Americans. __SpecificAimsTextDelimiter__ A. Specific Aims The broad objectives of this proposal are to identify genetic susceptibility factors that are associated with colorectal cancer (CRC) in African Americans (AAs). Of all US populations, CRC incidence and mortality are highest in AAs. Genetic susceptibility factors are believed to contribute to CRC development but have not been adequately studied in AAs. In this proposal, we will focus on single nucleotide polymorphisms (SNPs) identified in genome-wide association studies (GWAS). We aim to characterize common and rare variants and ultimately to determine putative functional variants in candidate CRC-associated regions. Because the genomes of individuals of African descent exhibit less linkage disequilibrium than those of European descent, AAs comprise an ideal population in which to identify functional variants. Understanding these factors will elucidate disease pathogenesis and may eventually lead to individualized risk assessment and disease prevention. To this end, we propose three aims: Specific Aim #1: Validate candidate CRC-associated regions in AA cases and controls. We hypothesize that SNPs discovered in GWAS in European populations are associated with CRC in AAs. To test this hypothesis, we have assembled an adequately powered series of over 1000 AA CRC cases and 1000 AA controls. Demonstration of significant associations in AAs, as we have shown on proximal 8q24, 10p14 and 15q23 in our preliminary data, will validate these SNPs as CRC-associated in AAs. Regions with SNPs not validated in AAs will be further evaluated using tag SNPs from public databases (1000 Genomes and HapMap) to determine if different SNP(s) in the region are associated in AAs. Regions containing SNPs validated in AAs will be further studied to identify putative functional variants. Specific Aim #2: Discover novel variants in CRC-associated regions by targeted resequencing in AA cases and controls. We hypothesize that there are novel variants (both common and rare) in candidate CRC-associated regions in AAs. To comprehensively identify novel variants in candidate regions, we will resequence 50 AA CRC cases and 50 AA controls using next generation sequencing technologies. Identification of novel common and rare variants in candidate regions will help localize functional CRC variants and will be made available to the broader scientific community. Specific Aim #3: Identify putative functional variants in candidate CRC-associated regions by bioinformatics analysis and association testing. We hypothesize that SNPs to emerge from GWAS are unlikely to be functional variants. Resequencing data will be analyzed bioinformatically to identify putative functional variants. Putative functional variants, novel variants and any variants in an LD block with CRC-associated SNPs will be tested for association in our large case-control series to determine variants with the strongest association signal(s) in a candidate region. Completion of this aim will produce a short list of putative functional variants in GWAS candidate regions to be carried forward in future studies. AIM 1 (yrs 1&2) GWAS SNP validation in AAs AIM 2 (yrs 2-4) Novel SNP discovery in AAs AIM 3 (yrs 3-5) Functional variant identification FUTURE AIMs Functional studies FiguBre. B1a:cCkognrcoeupntdualnmdoSdigenl iafnicdanticmee frame of proposed research plan GWAS=genome wide association studies; SNP=single nucleotide polymorphism; AA=African Americans